Advanced Normalization Tools

amKK `v
h?Bb TTHB+ iBQM b22Fb bmTTQ`i iQ /2p2HQT i?2 M2ti ;2M2` iBQM Q7 i?2 /p M+2/ LQ`K HBx iBQM hQQHb ULhbV 2+Qbvbi2K-
M QT2M@bQm`+2 HB#` `v bT MMBM; KmHiBTH2 bQ7ir `2 T +F ;2b M/ T`Q;` KKBM; H M;m ;2b i? i ?Qmb2b iQT@T2`7Q`KBM;
H;Q`Bi?Kb mb2/ rQ`H/rB/2 #v H `;2 +QKKmMBiv Q7 `2b2 `+?2`bX h?2 +Q`2 bQ7ir `2 HB#` `v- Lhb- Bb #mBHi mTQM M/
+QMi`B#mi2b iQ i?2 r2HH@FMQrM LA>@7mM/2/ AMbB;?i hQQHFBi UAhEV- r?B+? ? b ?BbiQ`B+ HHv #22M bB;MB}+ Mi `2bQm`+2 Q7
QT2M@bQm`+2 H;Q`Bi?KB+ M/ bQ7ir `2 BMMQp iBQMX Pp2` i?2 +Qm`b2 Q7 Bib /2+ /2@HQM; /2p2HQTK2Mi- Lhb ? b 2M #H2/
?mM/`2/b Q7 + /2KB+ M/ BM/mbi`B H b+B2MiBbib iQ K22i KQ/2`M [m MiBi iBp2 BK ;BM; M22/b rBi? T `iB+mH ` 7Q+mb QM Bbbm2b
BM #BQK2/B+ H BK ;BM;ě #`Q / ` M;2 Q7 TTHB+ iBQMb M/ Tm#HBb?2/ `2b2 `+? HBi2` im`2 b KTH2 i?2 bim/v Q7 Q`; MBbKb
7`QK bK HH MBK Hb iQ ?mK Mb b r2HH b i `;2i Q`; M bvbi2Kb bm+? b `2bTB` iQ`v- + `/BQp b+mH `- M/ M2`pQmbX hQ/ v-
Lhb Bb 7`22Hv p BH #H2- +`Qbb@TH i7Q`K iQQHFBi 7Q` KmHiBTH2 KQ/ HBiv BK ;2 T`Q+2bbBM; r?B+? +QMiBMm2b iQ b2i i?2
bi M/ `/ BM i?2 }2H/X >Qr2p2`- /2bTBi2 Bib bm++2bb BM K22iBM; i?2 `2 H@rQ`H/ M22/b Q7 #`Q / +QKKmMBiv Q7 BMp2biB; iQ`b-
i?2 ` TB/Hv ;`QrBM; mb2 Q7 BK ;BM;- M/ i?2 bbQ+B i2/ M22/ iQ bQHp2 2p2` KQ`2 +QKTH2t BK ;2 `2;Bbi` iBQM T`Q#H2Kb-
`2[mB`2 /vM KB+ mT/ i2 Q7 Lhb BM Q`/2` iQ K22i +m``2Mi M/ 2K2`;BM; M22/b Q7 i?2 #BQK2/B+ H `2b2 `+? +QKKmMBivX
h?Bb K DQ` mT/ i2- `2T`2b2MiBM; i?2 }`bi 2p2` TTHB+ iBQM 7Q` /2/B+ i2/ 7mM/BM; bmTTQ`i Q7 Lhb /2p2HQTK2Mi- rBHH
+QKT`Bb2 Q7 i?2 7Qm` bT2+B}+ BKb Q7 i?Bb T`QD2+i, RV iQ bB;MB}+ MiHv #`Q /2M i?2 ` M;2 Q7 KmHiBTH2 KQ/ HBiv `2;Bbi` iBQM
i bFb #H2 iQ #2M2}i 7`QK Lhb@# b2/ bQHmiBQMbc kV iQ KQ/2`MBx2 M/ 2tT M/ i?2 iQQHǶb bmTTQ`i Q7 p2`v H `;2 / i b2ib M/
b+ H #H2 +QKTmiBM; TH i7Q`Kbc jV iQ T`QpB/2 `272`2M+2 `2;Bbi` iBQM T`QiQ+QHb M/ p HB/ i2 i?2B` `2HB #BHBiv BM BMp2biB; iQ`@
/`Bp2M `2b2 `+? bim/B2bc M/ 9V iQ 2M? M+2 bmTTQ`i M/ Qmi`2 +? iQ i?2 mb2` +QKKmMBivX h?2b2 /2p2HQTK2Mib rBHH 2Mbm`2
i?2 HQM;@i2`K pB #BHBiv Q7 Lhb BM i?2 7 +2 Q7 bB;MB}+ Mi /p M+2K2Mib BM +QKTmiBM; M/ BK ;BM; i2+?MQHQ;B2b- b r2HH
b 2M #H2 M 2p2M #`Q /2` `2b2 `+? m/B2M+2 iQ H2p2` ;2 Lhb BM i?2B` b+B2MiB}+ QmiTmiX

Public health relevance
Narrative Advanced Normalization Tools (ANTs) is freely available software that provides image registration, segmentation, and other basic biomedical image processing and analysis functionality. ANTs has contributed to thousands of published studies spanning many areas of research, including in key public health areas such as cancer and heart, lung, and brain disease. This project will ensure that ANTs is available to basic scientists and clinical researchers in the future, as well as implement innovations that will allow even more investigators to take advantage of the tool's capabilities in their scientific work.